Thalamocortical Responsive Neurostimulation for the Treatment of Lennox-Gastaut Syndrome

Project Summary / Abstract
Lennox-Gastaut Syndrome (LGS) is a devastating form of childhood onset epilepsy with cognitive
dysfunction and very frequent generalized onset seizures (GOS) often leading to injury. Driven by the lack of
effective therapies and the demonstrated safety and efficacy of brain-responsive stimulation for medically
intractable focal onset seizures (FOS), this study will test whether brain-responsive neurostimulation of
thalamocortical networks (RNS-TCN) is a feasible strategy to treat LGS. Specifically, the project aims to:
(1) acquire preliminary evidence for safety and efficacy in treating GOS of LGS with RNS-TCN; (2) create an
interactive therapy-decision support system based on patient-specific computational network models and
machine learning to identify optimal lead placement and stimulation parameters.
Using the RNS® System, which is FDA approved for FOS, an early feasibility IDE study will be conducted
at 6 epilepsy centers in 20 patients with LGS and medically intractable GOS. The patients will be enrolled in
two cohorts of 10, with safety and efficacy milestones in the first cohort governing the enrollment of the second
cohort. Patients will have two depth leads placed bilaterally in the centromedian nucleus of the thalamus and
two subdural strip leads placed bilaterally on the medial prefrontal cortex. These targets are selected because
they are implicated in the onset and spread of GOS in LGS. Leads will be located within each target such that
stimulation maximally engages the thalamocortical network, guided by finite-element biophysical models
created from structural magnetic resonance imaging and diffusion weighted imaging. The finite-element
biophysical models will also be used to identify the initial RNS-TCN stimulation pathway and current amplitude.
During the blinded evaluation period patients will be randomized to receive either high-frequency short burst
(HFSB) or low-frequency long burst (LFLB) RNS-TCN, then enter a washout period before crossing over to
receive the other treatment condition. During the open label period stimulation parameters can be modified at
the discretion of the physician. Parameter adjustments will be informed by using a Bayesian optimization
model developed for specifically for each patient. All clinical and electrophysiological data collected during the
study will be used to identify a biomarker of clinical response; if found, these will aid future epilepsy research
and clinical practice. If safety is favorable and there is preliminary evidence for efficacy, then this early
experience will inform the design of a future larger feasibility study.
In addition to treating a population in need, this project engages in fundamental discovery of biomarkers in
generalized network epilepsies, and develops novel automated therapy selection policies that have the
potential to improve the lives of patients with LGS and other seizure disorders.

Public health relevance
Project Narrative Lennox-Gastaut Syndrome (LGS) is a devastating form of childhood onset epilepsy characterized by cognitive dysfunction and very frequent generalized onset seizures (GOS) that often lead to injury. Driven by the lack of effective therapies and the demonstrated safety and efficacy of brain-responsive stimulation for treating medically intractable focal onset seizures, this study will test whether brain-responsive neurostimulation can also be used to treat LGS. The intent of the proposed research is to test the safety and preliminary efficacy of responsive neurostimulation of thalamocortical networks (RNS-TCN) involved in GOS, to identify promising detection and stimulation approaches, and to characterize neurophysiological biomarkers of clinical efficacy that will aid future research and clinical practice.